Multidisciplinary Training in Pulmonary Research

PROJECT ABSTRACT (Changes in blue text)
This T32 application will establish a Multidisciplinary Training Program in Pulmonary Research at the
University of Rochester. We aim to provide multifaceted and personalized training opportunities that
will endow our trainees with the skills required to become successful independent researchers,
educators, and policy makers in the lung health sciences. Our T32 training program involves
internationally recognized, well-funded, and experienced faculty mentors at the University of Rochester
(UR). The UR is an equity-focused institution, and is actively recruiting trainees, faculty, and leaders
from diverse and under-represented backgrounds. We will espouse culturally responsive mentorship,
involving recognition of implicit bias, to create an inclusive and equitable learning environment where
all trainees feel valued and can reach their full potential. Our expert faculty are dedicated mentors, and
are committed to providing their trainees with in-depth knowledge and the critical thinking skills to apply
and communicate this knowledge to diverse audiences. This training program will support three
post-doctoral fellows and four pre-doctoral graduate students annually. Post-doctoral trainees
can be either MD fellows from any clinical fellowship in the School of Medicine and Dentistry (SMD), or
PhD post-doctoral fellows who are typically recruited by individual faculty mentors. Pre-doctoral
trainees can come from any accredited biomedical PhD program at the UR. All trainees will be
appointed to the T32 only after rigorous review by the Internal Advisory Committee, with careful
consideration about timing of appointment for MD trainees. The Training Plan involves five Core
Components: (i) Coursework, (ii) Mentored Research and Grant Writing, (iii) Grant Writing and
Scientific Communication, (iv) Multidisciplinary Training, and (v) Professional Development.
Our T32 has strong institutional support from by the Departments of Medicine, Pediatrics, and
Environmental Medicine, and is designed to foster collaborations between basic scientists and clinician
scientists. It is led by program leaders who are outstanding mentors, and experienced at addressing
challenges faced by PhD and MD researchers from diverse backgrounds. This training program will
develop the next generation of scientists conducting high-impact research to improve the health of
people suffering from lung diseases.

Public health relevance
PROJECT NARRATIVE The objective of this T32 Training Grant is to educate and train basic scientists and physician-scientists conducting high impact and innovative research that will improve the health of people suffering from lung diseases. We aim to recruit and train trainees from diverse backgrounds, and provide multifaceted and personalized training opportunities that will endow our trainees with the skills required to become successful independent researchers, educators, and policy makers in lung biology and pulmonary medicine.